ADMINISTRATIVE CORE

This Program Project consists of three individual related research projects and three cores. This core oversees the administrative needs of the program. The Program Project director (Dr. Warshaw) will maintain a staff who are responsible for financial records, progress reports, internal documents necessary for the functioning of the program project, interfacing with the subcontract business officers and administrative assistants and Project and Core leaders at the off-site institutions, and computer hardware, network, and software support.